Functional and cell-type specific axonal pathways in the primate brain

Project Summary/Abstract
Over the past decade, there have been transformative advances in three areas of mammalian neuroscience.
First, our ability to record from large populations of neurons has dramatically increased with the advent of new
electrode technologies and improved multiphoton imaging. Second, the study of brain connections in their
entirety, connectomics, has come into its own as a field. Most recently, there has been a revolution in the
classification of neuronal types, largely by probing which genes are translated into RNA in cells (transcriptomics).
What is lacking is a way to bring these three fields together, particularly in the studies of non-human primates
and humans.
The goal of the current RFA is to create innovative tools for use in humans and non-human primates. In particular,
two suggested topics are to develop: (1) “novel methods for tagging individual neurons such that cellular
components of a functional circuit can be explored” and (2) “innovative approaches to bridge scales of
experimental approach. Studies that can explore molecular and cellular mechanisms of neural activity in broader
contexts are encouraged.” To achieve these goals, we present an innovative approach to characterize neuronal
cell types in macaques and humans, combining transcriptomics, inter-areal connectivity and functional studies
at multiple scales, from individual neurons to entire brains. We will build the necessary tools to create integrated
atlases of individual brains that combine six modalities into a common reference frame: (1) functional MRI, to
measure functional properties of brain areas at 0.5-1 mm resolution, (2) widefield optical imaging, to map bulk
neuronal activity at the cortical surface with ~100 µm resolution, (3) multiphoton calcium imaging, to map
neuronal activity in individual neurons across multiple cortical areas, (4) diffusion tensor imaging (DTI), to map
axonal tracts in the white matter with 0.5-1 mm resolution, (5) “axonal connectomics”, to map projections of
individual myelinated axons from efferent cell bodies to their postsynaptic targets, and (6) multiplexed FISH, to
assay transcriptomic identities of the same cells whose physiology and projection targets have been defined.
Data from first three modalities will be collected, starting with in vivo studies of macaques and correlated with
subsequent analysis of brain tissue with the last three modalities. Only the last three steps will be used in the
study of human brain tissue, although functional MRI could, in principle, be obtained from research institutions
with appropriate programs for prospective studies.

Public health relevance
Project Narrative/Relevance This proposal will contribute to the fundamental question of how the connections that brain cells (neurons) make are determined by (1) the role those neurons play in brain activity and (2) the specific types of neurons they are, out of the hundreds of distinct types in the brain. Neurodegenerative diseases are common and devastating brain disorders that destroy neurons and their connections, so the proposed technical developments should open new vistas in our understanding of the relationship between neuronal properties (including disease markers) and the connections they make.